Fine-Scale Genome Folding Relative to Transcription and Location

ABSTRACT
This supplement will train a talented and high potential PhD student, Tim Reznicek, in critically needed high-
demand areas of bioinformatics and data analysis. Under the parent award, we proposed tracking transcription
relative to 3D genome folding as well as to develop tools that improve the analysis of genome-wide chromatin
organization assays. This supplement will support Tim’s training within a Bioinformatics & Systems Biology PhD
program to learn algorithm / software development, as well as the analysis of complex 3D genomic datasets.
The provided research plan includes details on the development of JukeBox, a tool which this student will develop
to measure, filter, and normalize noise in massive chromatin conformation matrices. We also include aims to use
serum stimulation for transcription synchronization, along with auxin-mediated acute degradation of Integrator
subunits, to investigate the coordination of transcription and the sub-genic 3D genome folding. These aims
address an intriguing and high-profile topic in the field of genome architecture, by answering once and for all,
which comes first: transcription or looping? As part of this research, the student will gain training and experience
in algorithm and software development, version control, maintenance, benchmarking, and implementation. Tim
will also be trained in hypothesis-driven bioinformatics, multi-‘omic data integration, and the analysis of large
complex 3D genome datasets. To facilitate Tim’s career, we have added a co-mentor structure, with Drs. Rowley
and Cummings, as well as supervisory committee members, who will support the candidates research and career
development activities, including presentation at conferences, interactions with the ENCODE community,
manuscript / grant writing, as well as leadership development experiences.

Public health relevance
PROJECT NARRATIVE This supplement will provide an PhD student, Timothy Reznicek, with valuable training opportunities in chromatin biology, bioinformatics, and leadership skills. They will use both established and innovative genomics and bioinformatics to track the progress of chromatin interactions during transcription and develop a new tool to measure “noise” within 3D genomic datasets. Training activities include professional development by networking at conferences, meetings between ENCODE labs, performing leadership roles, and participation in a series of career development workshops.